Transcriptomics of adherent endothelial cells for improved endothelialization of small-diameter vascular grafts

Project Summary
The long-term objective of this study is to establish an autologous endothelium on the blood-contacting surface
of implantable cardiovascular devices. This is critically important for providing hemocompatibility and minimizing
the risk of thrombosis, embolism, and other adverse outcomes in order to improve patient safety.
This objective directly supports the mission of the NHLBI to promote the treatment of heart diseases and
enhance the health of all individuals so that they can live longer and more productive lives. Many cardiovascular
diseases are treated with implantable devices. While lifesaving, these devices also carry an inherent risk of
thrombosis and embolism that requires administration of anticoagulation therapy.
The proposed study addresses the dire clinical need for establishing an endothelium within small-diameter
vascular grafts. Patients with coronary heart disease who require bypass surgery currently undergo autologous
vessel harvest because synthetic grafts demonstrate poor patency in small-diameter applications. Autologous
vessel harvest is associated with additional cost and significant donor site morbidity. In addition, a large and
growing number of patients do not possess suitable autologous vessel for reasons including preexisting vascular
disease, vein stripping, and previous harvest. Establishment of an autologous endothelium on small-diameter
bypass grafts is necessary for achieving acceptable patency rates without autologous vessel harvest.
The goal of the proposed research is to improve endothelial cell retention on vascular graft biomaterials by
identifying novel molecular signaling targets for molecular modulation strategies to promote cellular adhesion
strength. This is driven by our hypothesis that differential regulation of molecular signaling pathways involved in
cellular adhesion is responsible for a subpopulation of endothelial cells resisting detachment upon implantation.
Specific Aim 1 will identify molecular signaling pathways responsible for allowing a subpopulation of endothelial
cells to remain adherent upon exposure to physiological shear stress. RNA-sequencing will be used to compare
the transcriptome of all cells and adherent cells. The transcriptomics data will be used to identify molecular
signals that are highly differentially regulated in adherent cell subpopulations.
Specific Aim 2 will develop and test strategies to improve endothelial cell retention on vascular graft
biomaterials. A molecular modulation strategy will be developed to enhance cell adhesion by upregulating or
downregulating critical signaling molecules as appropriate. Cell retention will be compared under conditions of
physiological shear stress.
Specific Aim 3 will assess the biological performance of small-diameter vascular grafts seeded with endothelial
cells using a preclinical model. The most promising cell adhesion enhancement strategy will be used to
endothelialize grafts, which will be implanted into the carotid circulation of swine and analyzed for clinically
relevant outcomes including cell retention, patency, thrombosis, neointimal hyperplasia, and inflammation.

Public health relevance
Project Narrative The proposed research seeks to improve the safety and efficacy of implantable cardiovascular devices by establishing an autologous endothelium on the blood-contacting surface. This will minimize the risks of thrombosis and embolism while eliminating the need for anticoagulation therapy and the need for autologous vessel harvest during coronary bypass surgery. The proposed approach represents a novel combination of regenerative engineering and molecular modulation that may have broad applications throughout medicine.